Identification of Prospective Predictors of Alcohol Initiation During Early Adolescence

Project Summary/Abstract
Recent initiatives from the National Institute on Alcohol Abuse and Alcoholism have focused on the prevention
of child and adolescent alcohol use. To address this, the proposed project focuses on identifying salient,
prospective predictors and inferred causes of early alcohol initiation (EAI) or the consumption of a full drink
containing alcohol before the age of 16. The aims of the proposed project will test current assumptions of
predictors of alcohol initiation (Aim 1a), compare a priori risk factors with novel, data-driven risk factors (Aim 1b),
infer causal relationships between factors and EAI (Aim 2), and, as an exploratory aim, isolate individual
measures as predictors using machine learning techniques (Aim 3). To accomplish these aims, we will be
leveraging the Adolescent Brain Cognitive Development (ABCD) study consisting of over 11,000 youth
participants. ABCD provides multiple time points of neuroimaging, neurocognitive, and environmental measures
starting when youth are 9-to-10-years-old allowing for the incorporation of high-dimensional data into a single
framework. Thus, the resulting sample provides a unique opportunity to use advanced quantitative methods
including structural equation modeling, exploratory factor analysis, and random forest machine learning to
highlight what drives youth to initiate alcohol use during this risky developmental period. The outcomes of this
project aim to inform research on prevention and intervention of EAI to ultimately delay alcohol initiation to more
developmentally appropriate ages.

Public health relevance
Project Narrative Alcohol initiation before the age of 16 has been associated with an increased risk for alcohol use disorder; however, there is limited understanding of what prospectively predicts initiation. The proposed project addresses this limitation by leveraging the Adolescent Brain Cognitive Development (ABCD) study to test current assumptions of what predicts early alcohol initiation, propose novel, data-driven risk factors, and infer causal relationships between these factors and initiation. The goal of this work is to inform prevention-focused research to ultimately delay alcohol initiation to more developmentally appropriate ages.